Modulating stimulus intensity to improve clinical outcomes in aphasia treatment

Abstract
Determining the optimal intensity of treatment is essential to the design and implementation of any
treatment program for aphasia. Yet, treatment intensity is a complex construct and information on the variables
modulating it remain ambiguous and limited. Studies reported in the neuroscience and clinical literature
support the need for intensive treatment to induce long-term neuroplastic changes while the cognitive
psychology literature suggests that learning is best maintained with distributed schedules. A few studies have
looked at dose parameters for single word naming tasks, but there is limited evidence regarding dose
parameters for treatments that focus on training the production of larger units, such as sentences or even
connected discourse. One approach that is frequently used clinically and has evidence for its efficacy is script
training. Little is currently known regarding the optimum dose of script training (i.e., the number of repetitions
over time of each sentence within the script) that is required to promote the best outcomes.
In this proposal we conduct a two-factor RCT on the effects of modulating stimulus variables, specifically
stimulus practice distribution and stimulus repetition. We use a baseline script treatment that has experimental
support regarding its efficacy, and that allows the manipulation of these variables. To ensure independence
and fidelity, treatment is provided in a controlled computer environment (desktop and tablet). To avoid clinician-
related variables such as expertise and personality factors that may influence treatment, sentences are
modeled during treatment by an anthropomorphic agent with high visual speech intelligibility and affective
expressions.
With regard to “best outcomes”, generalization is the ultimate goal of any treatment approach. Therefore,
the primary outcome is a generalization measure of conversation. Secondary measures address short-term
acquisition, longer-term maintenance, and response generalization for assessing gain over baseline,
differential effects, and interactions. A mobile-connected wireless wearable laryngeal sensor allows tracking of
talk time at home and in the community as a measure of treatment effectiveness and transfer. For privacy, it
does not record audio.
Results and computational models of learning (generalization, short-term acquisition, and longer-term
maintenance) will contribute new evidence to fill critical gaps in current scientific understanding regarding the
effectiveness and clinical application of aphasia treatment approaches. More generally, findings will help to
inform clinical practice and treatment of neurologic communication disorders; the virtual clinician guided
intervention that the proposal develops has the potential to reduce costly clinician-client time otherwise
required for long-term rehabilitation.
.

Public health relevance
This study focuses on stimulus conditions that potentially help make treatment more effective for individuals with aphasia including stimulus repetition and practice distribution. Results will contribute new evidence to support the efficacy and delivery of the specific treatment studied (script training), as well as the application of practice principles to aphasia treatment in general. Results may further inform and facilitate the cost-effective treatment of other communication disorders across the lifespan that require costly face-to-face clinician-client interaction over extensive periods of time.